PROPHYLAXIS AGAINST MYCOBACTERIUM TUBERCULOSIS IN HIV PATIENTS

Prophylaxis against Mycobacterium Tuberculosis (MTB) in Patients who are Infected with the Human Immunodeficiency Virus (HIV) and suspected or confirmed latent MTB Infection (ACTG 177).